Early life aflatoxin B1 exposure and epigenetic programming in Nigerian Newborns

Project Summary
Aflatoxin B1 (AFB1) is a major cause of hepatocellular carcinoma (HCC) in Sub Saharan Africa, where
aflatoxin contamination is common. In these areas, exposure to AFB1 starts early in life through maternal
routes during pregnancy. Populations in these countries experience early onset of HCC, and in utero AFB1
exposure may be a contributing factor to the onset of the disease. Exposures to nutrients, toxic chemicals and
biological agents during gestation and early childhood play a critical role in determining susceptibility to
diseases later in life. The mechanism of early onset of carcinogenesis may include epigenetic changes in
tumor suppressor genes (TSGs). Our previous rodent study showed that in utero AFB1 exposure can alter
DNA methylation of TSGs. It is necessary to investigate the impact of in utero AFB1 exposure on methylation
and expression of TSGs in humans. The overall hypothesis is that in utero AFB1 exposure will differentially
methylate TSGs, and this methylation will inversely correlate with the expression of the TSGs. The overall
objective of this project is to establish a pre-birth cohort and study the association between in utero exposure
to AFB1 and DNA methylation changes in TSGs of newborns in Nigeria. To achieve this, we will recruit
pregnant women in the first trimester from two Nigerian hospitals serving a rural and an urban area. We
hypothesize that Nigerian women will have a range of AFB1 exposure levels detectable in plasma. We
hypothesize that in utero AFB1 exposure will be associated with differential methylation and expression of
TSGs in cord blood samples. The specific aims of this project are to 1) determine the levels of AFB1 in the
plasma of pregnant women, using HPLC, collected during the first and third trimesters of pregnancy, and
newborns (cord blood), 2) assess the DNA methylation of TSGs in the cord blood via pyrosequencing and to
determine if AFB1 concentration is associated with the levels of DNA methylation, 3) determine the expression
of TSGs in the cord blood using real-time quantitative PCR and determine if gene expression is inversely
correlated with methylation changes in the TSGs. The findings of this study will provide data on AFB1
exposure among pregnant women in Nigeria and its subsequent effect on the epigenome of newborns. This
data will provide direction for future research developing epigenetic biomarkers of AFB1 exposure as well as
investigating epigenetic mechanisms associated with prenatal exposure to AFB1 and the risk of developing
liver cancer in Africa. This research direction may provide insight into reducing the incidence of this cancer in
sub-Saharan Africa, especially in countries such as Nigeria, where AFB1 exposure is highly prevalent. Through
this research, the PI will become a leader in environmental epigenetics, studying how early-life exposure to
environmental contaminants of Public Health concerns in Africa contributes to the development of non-
communicable diseases later in life.

Public health relevance
Project Narrative Aflatoxin B1 (AFB1) is a liver carcinogen that is a common contaminant of foods in sub- Saharan Africa where exposure starts very early in life during pregnancy. This study aims to find out if early life AFB1 exposure is associated with altered regulation of tumor suppressor genes in Nigerian newborns. The findings of this research could provide an understanding of how early- in-life AFB1 exposure increases the risk of early-onset liver cancer.